Non-canonical mechanisms of translation initiation and regulation

ABSTRACT
My previous work showed specific mutations in mRNAs activate initiation at non-canonical start codons (e.g.,
GUG, ACG) resulting in expression of neurotoxic proteins that cause multiple human disorders. However, non-
canonical translation is not restricted to atypical start codons or necessarily connected to pathology; cells rely
on alternative mechanisms to respond to specific states to translate mRNAs with spatiotemporal precision. Our
basic understanding of non-canonical translation is incomplete, and the long-term goal of this research
program is to understand how and why non-canonical translation occurs in cells. We will fill gaps in our
understanding of non-canonical initiation by addressing two fundamental questions. What mechanisms enable
alternative initiation factors to support translation? Which aminoacyl tRNAs other than Met-tRNAiMet are used
for initiation? Our previous and current work has also discovered unconventional translational regulatory
mechanisms that use ribosome queuing and non-canonical RNA-binding domains (ncRBDs). We will establish
how unconventional regulatory mechanisms such as ribosome queuing are used as cellular sensors of
elongation to drive apoptosis, and how proteins with ncRBDs regulate translation. My research program will
shed new light on how the translation machinery is used to create a diverse repertoire of initiation and
regulatory mechanisms. In doing so, we will expand our understanding of the coding potential of the genome
and how alterations in protein synthesis lead to human disease.

Public health relevance
PROJECT NARRATIVE Protein synthesis is essential in all domains of life. Our recent work has shown that deviations from the canonical model of translation are frequent and directly cause to human disease. This research program seeks to mechanistically define how non-canonical initiation and regulation occurs.